CORE--BIOCHEMISTRY FACILITY

Description: The Biochemistry Core will perform some of the biochemical measurements in support of some of the projects in this Program Project. The Core will also be responsible for tracking and storing blood samples in an orderly manner, distributing blood samples to various laboratories, and disseminating the results to the investigators and physicians. The Core description was modified with deletion of the micronutrient/vitamin and hepatitis serology. Most of the biochemistry testing will be carried out by the hospital laboratory. However, some test will be conducted in the GCRC laboratory.